Direct Electrical Measurement of Proteasome Activity for Single-Molecule Protein Sequencing

Project Summary
Direct electronic measurement of protease activity may yield signals that can be interpreted in terms of the
amino acid sequence being processed by the proteasome. This proposal seeks to explore these signals (using
a scanning tunneling microscope) and, from these experiments, layout the design parameters for solid state
devices that can be multiplexed. As simple 2 terminal devices with no optical or electrolyte reservoirs (as
required for nanopore devices) current technology should yield die with >10,000 devices, leading to possible
total read speeds of 106 amino acids per second. As a single-molecule counting device, the dynamic range
would be limited only by the recording time, so that a range of 109:1 may be possible. In this exploratory R21
phase, we will synthesize two types of proteasome with chemical tags that allow for incorporation into an
electronic circuit, and record the current variations that occur as different peptides are processed. We will
explore the processing of intact proteins when an unfoldase is also present. We will use machine learning to
explore ways in which amino acid sequence information can be extracted from the stochastic electronic signals
that we expect the proteasomes will produce.

Public health relevance
Project Narrative Direct electronic measurements of proteasome fluctuations as peptides are processed have the potential for sequencing proteins at the single molecule level, and doing so rapidly and in a highly multiplexed manner. This would allow the identification of rare proteins currently not accessible to mass spectrometry, and the sequencing of rare variants.